Electrosprayed Core-Shell Microparticles as a Pulsatile Vaccine Delivery Platform

PROJECT SUMMARY/ABSTRACT
Every year an estimated 19.4 million children do not receive the set of vaccines recommended by the World
Health Organization, leading to 1.5 million vaccine-preventable deaths.1,2 A majority of undervaccinated children
live in low- and middle-income countries and often have limited access to healthcare.2,3 Nearly 6 million of these
children receive at least one vaccine dose, but remain at risk because they have not completed the full dosing
regimen.4,5 A vaccination method that delivers all doses of a vaccine, or multiple vaccines, in a single injection
would enable children with even one-time access to healthcare to be fully protected from the corresponding
infectious disease. Unfortunately, most controlled-release drug delivery systems exhibit continuous release
kinetics, which is vastly different from traditional soluble vaccines administered in multiple discrete doses over a
course of months. One recent study has described the development of biodegradable microparticle platform with
a polymer shell encapsulating a vaccine-loaded core that exhibits delayed, pulsatile release after a period
determined by the polymer degradation rate.6 By injecting patients with a mixed population of particles with
different degradation rates, vaccine can be released as discrete pulses, thereby mimicking traditional vaccination
schedules known to be safe and effective. Unfortunately, the original microparticle production method negatively
affects antigen stability, requires the use of large-gauge needles, and is low-throughput. This project seeks to
overcome these challenges by preparing microparticles using coaxial electrospraying, a single-step fabrication
process that can produce a single aqueous, vaccine-loaded core surrounded by a shell of polymer. This proposal
first aims to create small core-shell microparticles with dense polymeric shells that demonstrate the delayed,
pulsatile release of macromolecules in vitro and in vivo. Fluorescently tagged proteins will be used as model
vaccines to study the effects of particle size, shell density, relative wall thickness, and post-processing on release
kinetics. After identifying formulations that achieve pulsatile release, we will then optimize processing conditions
to maximize encapsulated antigen stability. An enzymatic reporter and a pH-sensitive dye will be added to the
core and tested at several stages of the particle life cycle to monitor microenvironmental conditions during
fabrication, storage, and release. Electrospraying materials and parameters will be adjusted to minimize changes
to protein conformation that could result from solvent interactions, thermal instability, and particle acidification,
which may affect the immune system's ability to create neutralizing antibodies. Although further optimization will
be required to fine-tune conditions for specific vaccines, this project will provide a framework for quickly
developing controlled-release vaccine formulations. Ultimately, these particles could serve as a key tool in the
fight against infectious disease both in the developing world where resources are limited and in the developed
world, where uninsured children and rural communities show consistently lower vaccination coverage.7

Public health relevance
PROJECT NARRATIVE Each year, 19.4 million children fail to receive a full series of recommended vaccines—largely due to inadequate vaccine distribution in the developing world—which results in 1.5 million vaccine-preventable deaths annually. Injectable microparticles that release vaccine at predetermined time points mimicking normal vaccination schedules present an opportunity to protect children from infectious diseases without the need for multiple injections over a course of months. This proposal seeks to use coaxial electrospraying to produce polymeric microparticle formulations that release encapsulated proteins in their native conformation as a burst at material- dependent time points to provide immunity after only a single injection.